STAG2 modulates environmental toxicant exposures and epigenomic heterogeneity

ABSTRACT Epidemiological evidence suggests that environmental exposures during development may play a
role in disease susceptibility later in life, and researchers have hypothesized that epigenetic changes induced
by common toxicants such as pesticides, herbicides, endocrine disruptors, and heavy metals may be
facilitating this link 1,2. The mechanisms by which these changes are induced and propagated remain
challenging to dissect, largely because environmental toxicant induced changes are often 1) subtle when
assayed across the bulk cell population, 2) transient in nature and therefore difficult to reproducibly detect,
and/or 3) randomly distributed throughout the genome, making reproducibility and measurement of statistical
significance challenging. In fact, most studies trying to link toxicant exposures directly to frank cellular
transformation, including our own, have been relative failures. In virtually all cases, in order to see overt
transformation, exposure studies need to be conducted in cell or animal models that already have baseline
genetic or epigenetic changes that facilitate the progression to malignancy.
We have exciting preliminary data that demonstrates that Ewing sarcoma cells demonstrate a
significantly elevated level of transcriptional and replication stress (RS), and we propose that environmental
exposures may not only induce RS and activate the RSR, but also cause epigenetic changes that precondition
cells to allow for survival following expression of driver fusion proteins despite elevated levels of RS. This
proposal will focus our efforts on understanding the downstream effects of TCDD exposures in mesenchymal
stem cells (MSC) when paired with 2,4-D and 2,4,5-T and investigate the role of STAG2 in modulating
downstream molecular events associated with environmental toxicant exposures. Our overall hypothesis is
that environmental toxicant exposures cooperate with STAG2 loss to increase replication stress, ultimately
leading to genomic and epigenomic instability, and creating a permissive epigenome for fusion gene
expression. Three Specific Aims are proposed:
SPECIFIC AIM 1: To determine whether environmental toxicant exposures increase baseline levels of
replication stress in iMSC and cooperate with STAG2 loss to lead to epigenomic remodeling.
SPECIFIC AIM 2: To determine whether environmental toxicant exposures cooperate with STAG2 loss to lead
increased clonal genetic and epigenetic heterogeneity.
SPECIFIC AIM 3: To determine whether environmental toxicant exposure leads to a permissive epigenome for
survival of pre-malignant cells following fusion protein expression.

Public health relevance
NARRATIVE Environmental toxicant exposures play a key role in the regulation of the epigenome, but the mechanisms remain unclear. In this proposal, we hypothesize that toxicant induced replication stress, paired with defective repair due to STAG2 loss, drives pre-malignant cell evolution and creates a permissive epigenome for transformation. This proposal is focused on understanding the molecular mechanisms by which 2,3,7,8-tetrachlorodibenzo-p-dioxin (TCDD), alone or in combination with 2,4-dichlorophenoxyacetic acid (2,4- D) and 2,4,5-trichlorophenoxyacetic acid (2,4,5-T) affect the replication stress response (RSR) and contribute to genetic and epigenetic heterogeneity in these tumors.